Alzheimer’s disease and chronic pain

Alzheimer’s disease (AD) is often co-morbid with chronic pain. Given the anticipated increase in magnitude and
median age of the global population, the interaction of these 2 clinically unmet needs will become an increasingly
pressing challenge. The reported prevalence of chronic pain in AD patients is 45.8% in the 50 million people
worldwide. Pain may be underestimated in AD patients as they may be unable to communicate their pain,
particularly in more severe stages of dementia. Chronic pain may result from injuries resulting from falls (e.g.,
fractures, which are high in AD populations compared to non-AD population), surgeries, diseases, etc.
Additionally, AD-specific neurodegenerative changes may affect a multitude of regions implicated in the pain
control. Despite this, the effects of AD-associated neurodegeneration on the experience of pain remain
equivocal, and whether this may result in differential responses to analgesic treatment remains largely
unexplored. Therefore, the main goal of this supplement is to establish the first comprehensive and rigorous
studies to address the following questions: Is the neuropathic pain response altered (enhanced or decreased) in
AD compared to non-AD mice? Are there differences between AD models of tauopathy and beta-
amyloidogenesis? Is effectiveness of analgesic pharmacotherapy altered in AD models? Conversely, does the
pain state affect AD-associated cognitive functioning and AD pathology? Is there evidence for age- and sex-
dependent effects? Practically, it is impossible to advance the field of pain research and management in the
context of AD without addressing these questions. Aim 1. We will test the hypothesis that pain sensitivity in AD
mouse models with chronic neuropathic pain is enhanced compared to wild-type. We will use various behavioral
assessments of sensory and ongoing qualities of pain, two different AD mouse models (that address tauopathy
and amyloidogenesis), a well-established chronic neuropathic pain model. We will test the analgesic efficacy of
clinically relevant analgesic (e.g., gabapentin). For enhanced rigor as well as to have a holistic picture of
neuropathic pain and AD interaction, we will determine the effects of neuropathic pain on cognitive decline and
key mechanisms driving the pathogenesis of AD (e.g., levels of amyloid β, tau) in the brain areas involved in AD.
The proposed studies will significantly advance the field of pain and AD by providing fundamental knowledge
about the interaction between neuropathic pain, analgesic effectiveness and AD while considering age and sex
differences. A potential outcome would be that AD exacerbates pain and alters the efficacy of analgesics. This
concept would create a paradigm shift for therapeutic regimen in neuropathic pain management in the context
of AD with significant clinical implications. This project would provide the rationale for an in depth analysis of
mechanisms underlying the pain-AD interaction in subsequent studies to create the knowledge basis required
for the development of appropriate therapeutic interventions. Therefore, the proposed work is novel and
significant. The proposed studies fit with NOT-AG-21-018 because the parent grant is for pain research.

Public health relevance
NARRATIVE The effects of Alzheimer’s disease (AD)-associated neurodegeneration on the experience of pain remain equivocal, and whether this may result in differential responses to analgesic treatment remains largely unexplored. The proposed studies will significantly advance the field of pain and AD by providing fundamental knowledge of the status of neuropathic pain (magnitude and duration). Furthermore, this knowledge will stimulate new experimental pain, therapeutics and mechanistics, in the context of AD.